District of Columbia Center for AIDS Research (Dev Core)

PROJECT SUMMARY
The aims and activities DC CFAR Pathway Program are aligned with and enhances those of the
Developmental Core. The goal and activities of both the Pathway Program and Developmental Core work
synergistically to develop a community of HIV researchers that supports diversity, dynamic mentorship,
interdisciplinary researchers that now spans from HS through early stage and transitioning investigators.

Public health relevance
Project Narrative To widen the HIV research career pathway for early-stage scholars from diverse groups, the National Institutes of Health supported the development of the Centers for AIDS Research (CFAR) Diversity, Equity, and Inclusion Pathway Initiative (CDEIPI). The local CFAR Pathway program, now in its third year under supplemental funding, was developed to enhance the current aims of the Developmental Core by creating a pathway for high school and undergraduate students to engage in HIV research. The pre-professional workshops, didactic seminar series and proposed one-credit course focusing on HIV and Health Disparities align with our aim to provide educational and networking activities that promote multidisciplinary, cross- institutional, and community collaborative HIV research.